Administrative Core

Modified Project Summary/Abstract Section

Administrative
The University of Miami (UM) CFAR is applying for its 4th competitive renewal under the continuing leadership of Savita Pahwa, MD as Director, and Mario Stevenson, PhD as Co-Director. Our CFAR leaders complement each other and brings distinctive perspectives to the forefront to develop a rich research environment that is positioned to succeed in academia, community service, education and mentorship. The relevance of the Miami CFAR is underscored by the fact that it is the only CFAR in Florida, the State with the highest rates of new HIV infections in the country with Miami-Dade County (MDC) with the most new HIV diagnoses among counties. The Administrative Core (Core A) of the Miami CFAR serves as the oversight branch of the CFAR and supports the CFAR’s mission which is to advance HIV/AIDS research by providing scientific leadership and developing an infrastructure that fosters integration of basic, clinical, and behavioral sciences, promotes education and mentorship, engages the community and partners with the Florida Department of Health (FDOH) to prevent, treat and cure HIV/AIDS, the ultimate aim being to end the HIV epidemic (EHE). The Specific Aims of Core A are: Aim 1. Provide scientific leadership and establish lines of communication with School leadership and the National Institutes of Health (NIH) and conform with National CFAR objectives and guidelines. Aim 2. Coordinate activities of Cores, Scientific Interest Groups (SIGs) and the Scientific Working Group (SWG). Aim 3. Leverage State resources and University of Miami Departments/Centers/Institutes for faculty recruitment and access to additional resources. Aim 4. Sponsor educational activities, foster collaborations and establish linkages within and outside campus. Aim 5. Organize internal and external advisory committees and grant reviews. The Internal Advisory Committee (IAC) and External Advisory Committee (EAC) are essential resources and oversight committees for the CFAR. The IAC members represent various experts who participate in the annual Strategic Planning to make recommendations on the CFAR program. The EAC members are experts aligned to the Miami CFAR priorities who provide critical review of the CFAR and both committees provide productive feedback towards the larger program, infrastructure, scientific and research activities, and opportunities for advancement. Aim 6. Establish policies and procedures and provide fiscal oversight for governance of the Miami CFAR. The Miami CFAR has been able to mount a response to expand its impact through UM’s extensive clinical research network and Core activities, bolstered by the EHE initiatives.